BIOCHEMICAL TOXICOLOGY OF THE NITROSOUREAS AND THE THIOL MODULATING AGENT, BSO

The objective of this project is to understand the biochemical mechanisms for the target organ toxicity of anticancer drugs. These studies have focused on two main areas of research: 1) the first project deals with the mechanism for the renal toxicity of MeCCNU and related nitrosoureas (i.e., CCN, BCNU, chlorozotocin); and 2) the second study involves investigations on the use of buthionine sulfoximine as a thiol modulating agent in cancer chemotherapy. Studies completed this year have demonstrated that: a) carbamyflation-mediated reactions may not be necessary to nephrotoxicity to develop following the administration of nitrosourea anticancer agents; b) the alkylation of kidney DNA may be an important cellular target for nitrosourea nephrotoxicity; c) glutathione plays an important protective role against MeCCNU-induced renal toxicity; d) hepatic drug metabolizing enzymes can activazte MeCCNU and CCNU, but not PCNU, to more polar and more reactive alkylating intermediates which can bind macro-molcules in vitro; e) a liver-derived metabolite of MeCCNU may be responsible for the renal toxicity of the parent nitrosourea; f) in vivo administration of buthionine sulfoximine markedly reduced normal tissue, and L-PAM resistant L1210 tumor glutathione levels following a single dose of BSO, or after a multiple dosing regimen; g) of the normal tissues, the kidney was the most sensitive, and the bone marrow the most resistant, to thiol depletion by BSO; h) BSO increased the renal and hepatic toxicity of MeCCNU in F344 rats and increased the lethality of L-PAM in BDF mice.